Administrative and Outreach Core

PROJECT SUMMARY
The Administrative and Outreach Core of the Kids First Data Resource Center will drive the use of the KF DRC
data and tools through dynamic innovative targeted education and training, comprehensive personalized user
support, compelling outreach and engagement, cross pollination efforts with key strategic partners, and
efficient and effective administration to ensure the goals of the KF DRC and cores are successful. The
Administrative Core is co-Led by Ms. Jena Lilly and Dr. Adam Resnick, and comprises experienced scientific
educators and seasoned administrative, project, and financial managers with decades of large scale program
management. The Administrative Core will be used by all cores in the KF DRC.